Sequence-to-function models for mechanistic investigations of personal genomes

Recent advances in functional genomics and computational modeling and hardware have ushered in a new era
of sequence-to-function (S2F) deep learning models, allowing the direct prediction of functional outcomes from
DNA sequences. We are poised to build comprehensive models of gene regulation and precisely predict gene
expression consequences of arbitrary genotypes. However, two significant challenges limit the potential of
current models. Firstly, current models are not able to correctly predict the subtle gene expression consequences
that arise from natural genetic variation. Secondly, current models can only make accurate predictions for the
cellular contexts with abundant functional genomic training data and are not applicable to contexts important for
many diseases such as early developmental time points and difficult to isolate cell types. Our proposal aims to
address these challenges and advance the field. Aim 1 develops S2F models that are performant on the full
spectrum of natural genetic variations. Current S2F models generalize across genomic regions, but struggle
to generalize across diverse genotypes represented in personal genomes, due to the subtleties in gene
expression changes. We propose a novel and general learning framework that integrates allele-resolved
functional genomic data, enhancing the model's ability to predict variant effects. This framework employs custom
loss functions and learning algorithms for efficient utilization of personal genomes and allele-resolved datasets.
Aim 2 introduces modularized model architectures that improve generalization and adaptability,
particularly in scenarios with limited data. Gene expression regulation involves complex processes, each
with a distinct relationship to DNA sequence. We propose factorized models that utilize biological prior
knowledge to constrain the model and decouple its parameters to correspond to distinct biological processes.
Regularizing the model with known biological principles enhances generalization, yields interpretable
predictions, and enables context-specific fine-tuning in data-limited settings. Aim 3 applies these enhanced
models to study regulatory mechanisms underlying neurodevelopmental disease. Collaborating with
domain experts, we will investigate how sequence variations affect gene expression in autism spectrum disorder
(ASD) and schizophrenia (SCZ). ASD and SCZ involve abnormalities in brain development that may occur even
before birth. Hence, functional data from the relevant cell-types and developmental time points is limited. Here,
we will apply our models to Whole-Genome Sequencing data collected from SCZ and ASD patients to predict
gene expression values across genome and brain cell types across early developmental time points. By
associating the resulting imputed gene expression values with disease outcome, our approach will drastically
reduce the multiple testing burden that is currently hampering rare non-coding variant investigation in complex
disease. In summary, our methods will offer powerful computational tools to study and interpret personal
genomes, enabling mechanistic investigation of the full spectrum of genetic variation in complex disease.

Public health relevance
Project Narrative Recent advances in DNA sequencing technologies now enable scientists to quantify differences between individuals’ genomes. This ability is now driving many applications in both basic science, for example to discover root causes of heritable diseases, and therapeutics, for example to develop personalized treatments. Here, we propose new computational methods to make predictions about disease susceptibility and identify biological processes that lead to disease based on a person’s genome in more effective and complete manner.